The Molecular Basis of Nasal Pit Morphogenesis and its Role in Upper Lip Formation

Project Summary/Abstract
While cleft lip, with or without cleft palate, is one of the most common craniofacial birth defects, the molecular
and cellular etiology of the phenotype is incompletely understood, and the fundamental morphogenesis that
underlies upper lip formation remains largely mysterious. This is in part due to a complex three-dimensional
topology of the developing midface over a series of several days during mid-gestation. At the onset of lip
development, the frontonasal process (FNP) cranial ectoderm undergoes substantial morphological change
starting with bilateral thickening and formation of the epithelial nasal placodes, which undergo invagination to
form nasal pits, separating the medial nasal processes (MNP) from the lateral nasal processes (LNP). Fusion of
the MNP and the LNP encloses the nasal canals and initiates the formation of the upper lip, which also involves
fusion of the MNP and maxillary process (MXP). While some studies have focused on the regulation of these
final fusion steps, much less attention has been paid to the cellular drivers and molecular regulators of the
significant preceding morphologic changes during nasal pit formation as it contributes to proper lip formation.
Previous reports together with preliminary data presented here, demonstrate that loss of TGFβ Receptor I (Alk5)
within the craniofacial ectoderm leads to cleft lip. TGFβ signaling via TGFβRI can activate both canonical and/or
noncanonical downstream signaling pathways in a context specific manner, leading to transcriptional and/or
cytoskeletal changes critical in many tissue morphogenesis events. Disruption of TGFβRI or actomyosin
contractility through the compound loss of the two major mammalian embryonic non-muscle myosins, NMIIA and
NMIIB, results in cleft lip and defects in early nasal pit morphogenesis.
This project will test the central hypothesis that nasal pit morphogenesis, driven in part by tissue bending driven
by actomyosin contractility, causes conformational changes that bring the MNP/LNP/MXP in proximity for fusion
and establish midface structure, and that signaling via TGFβRI is a key regulator of this process. Aim 1 will
establish the cellular dynamics driving nasal pit morphogenesis as it contributes to lip formation. Aim 2 will
determine how TGFβ signaling via TGFβRI drives nasal pit morphogenesis and lip formation. This study will be
a key step in understanding how upper lip morphogenesis occurs, and the mechanisms underlying cleft lip.

Public health relevance
Project Narrative Cleft lip with or without cleft palate, is a leading birth defect worldwide, but the fundamental morphogenesis that drives upper lip formation remains largely mysterious. Our preliminary data indicate that improper nasal pit morphogenesis is a driver of cleft lip and that TGFβ signaling through TGFβRI is a key regulator of this process. The experiments outlined in this application will contribute to understanding the dynamics driving nasal pit morphogenesis as it contributes to lip formation and cleft etiology.